Restoring Cortical Network Function in Rett Syndrome

PROJECT SUMMARY/ABSTRACT
Autism spectrum and related neurodevelopmental disorders are thought to arise from widespread mild synaptic
dysfunction that leads to an altered trajectory of brain network development (Johnson et al., 2015). In Rett
syndrome (RTT), a debilitating neurodevelopmental disorder, loss-of-function mutations in MECP2 on the X
chromosome lead to a devastating loss of language, motor and visual function at the behavioral level. Yet no
therapy exists to stop or reverse the cognitive decline. Previous work in RTT mouse models reveal synaptic- and
network-level defects that precede symptom onset. Mecp2-deficiency alters the timing of excitatory synaptic
maturation in excitatory and inhibitory neurons in the developing cortex (Mierau et al, 2016). Microelectrode
array (MEA) recordings and calcium imaging of neuronal activity in cultured murine cortical neurons reveal delays
in the development of functional connectivity in the Mecp2-deficient cortical networks including smaller network
size, weaker strength of connectivity and impairments in the development of network topology including features
that predict local and global efficiency of the networks (Dunn et al, unpublished). These findings reveal cellular-
scale deficits in information processing that likely underlie the cognitive impairment in RTT and could be targeted
with novel therapies to rescue cognitive function. In my proposed K02 and subsequent R01 research, we will
translate this approach to a human in vitro cellular model of RTT. In Aim 1, air-liquid interface cortical organoids
(ALI-COs) will be generated from RTT patient-derived induced pluripotent stem cells (iPSCs) and allogenic
controls to first identify network-level defects in the development of cortical networks. The ALI-CO model shows
further cortical maturation than previous organoid models and avoids the necrotic core (Giandomenico et al.,
2019). In Aim 2, we will target excitatory synaptic maturation in a specific type of inhibitory neuron in the MeCP2-
deficient ALI-COs using novel cell-type specific modulators we identified (Mierau et al, unpublished). Our goal
is to prevent early synaptic defects and ensure the formation of network activity and topology necessary to
support cellular-scale information processing. This strategy could be used in our future R01 research to prevent
the cognitive decline in RTT. In Aim 3, we will develop novel tools for detecting and modulating network dynamics
in the MeCP2-deficient ALI-COs as a platform for testing strategies to rescue network function in RTT after the
cognitive decline has occurred. Re-expressing Mecp2 in adult Mecp2-deficient mice rescues many behavioral
and synaptic features, raising the hope that neuronal function can be rescued in RTT even after the cognitive
decline. We will next test dynamic electric, optogenetic, and pharmacologic approaches for modulating cognitive
function. This will support the subsequent R01 aims in Year 4 and 5 of the K02 award to test whether modulating
network function in real-time can rescue network function in RTT ALI-COs. This strategy would facilitate
screening of novel therapies to unlock function in symptomatic RTT patients and could be applied in the future
to develop new therapies for autism spectrum and other cognitive disorders.

Public health relevance
PROJECT NARRATIVE This project will provide mechanistic insight and novel therapeutic targets for treating cognitive dysfunction in Rett syndrome, a neurodevelopmental disorder with loss of cognitive, motor and sensory function in early childhood. The project uses a novel human cerebral organoid model–3D neuronal cultures generated from induced pluripotent stem cells from patients with Rett syndrome–to study how brain cells form functional connections in early life and how these networks are altered by the genetic change in Rett syndrome. Our goal is to identify strategies for restoring cellular-scale brain network activity and development to reduce disability and enable children and adults with Rett syndrome to more fully participate in their family and community life.